Developmental Research Project Program (DRPP)

DRPP Project Summary
DEVELOPMENTAL RESEARCH PROJECT PROGRAM
The goal of the Developmental Research Project Program (DRPP) is to strengthen and expand the research
programs of the participating primarily undergraduate institutions (PUIs) through funding of peer-reviewed
research projects and strong mentoring of faculty and students. These activities will increase the research
training of students, as well as the experiences of faculty pursuing biomedical research projects. The program
will produce positive impacts on filling the pipeline of biomedical scientists within the state and expanding the
workforce. Developmental Research Projects (DRP) include: New Faculty Start Up projects which a aimed at
attracting more biomedical researchers to the state and help them establish a research laboratory; Pilot
Research projects aimed at exploring a biomedical research idea through a peer reviewed process; Full
projects, which aim to expand the successes of Pilot projects and helping investigators establish a research
program in his/her laboratory; and the Developmental Translational Projects, which will promote translational
research in collaboration with Louisiana’s IDeA-CTR, Louisiana Clinical and Translational Science Center (LA
CaTS). LA CaTS will not only support the projects through collaborative intellectual efforts and infrastructure,
but will also supply one-third of the funding. In addition, Shared Instrumentation Grants through matched
funding with PUIs will help with increasing the research infrastructure of the PUIs. All of the projects and PIs
will undergo a through quarterly evaluation by the Steering Committee (SC) and annually by the External
Advisory Committee (EAC).
The goals of the DRPP will be met by the following Specific Aims:
Specific Aim I. To promote, identify, select in a competitive manner and, mentor Development
Research Projects from PUI applicants.
Specific Aim II. To Evaluated progress of Developmental Research Projects quarterly using a Logic
Model and annually by the EAC. External evaluation by American Association for the Advancement of
Science’s Research Competitiveness Program (AAAS RCP) will be used twice during the course of the
program.

Public health relevance
DRPP Project Narrative DEVELOPMENTAL RESEARCH PROJECT PROGRAM The goal of the Developmental Research Project Program (DRPP) is to strengthen and expand the research programs of the participating primarily undergraduate institutions (PUIs) through funding and mentoring peer-reviewed research projects. These activities will increase the research training of students, as well as the experiences of PUI faculty. The program will have positive impacts on filling the pipeline of biomedical scientists within the state and expanding the workforce.